Extending Chimeric Antigen (CAR) T cell therapy to thoracic cancers

Overall Summary
The goal of this Program Project is to develop approaches to reproduce the success of adoptive T cell transfer
using chimeric antigen receptor (CAR) transduced T cells for hematologic malignancies to solid tumors, with a
focus on thoracic malignancies (non-small cell lung cancer [NSCLC] and malignant pleural mesothelioma
[MPM]. An important scientific theme in all of the projects is an exploration of the ability of CAR T cells to
induce epitope spreading, that is, their ability to stimulate endogenous B and T cell responses against the
tumor- a key component for success in solid tumors. This PO1 will have 3 projects which will be supported by
3 Cores. Project 1 will conduct clinical trials using CAR T cells. In Aim 1, we will continue a clinical trial in
patients with NSCLC and MPM using a newly designed and improved anti-mesothelin-CAR construct. In Aim
2, we will conduct a Phase 1 clinical trial to evaluate the potential safety and clinical activity of a CAR targeted
to tumor stroma (cancer associated fibroblasts) by engaging fibroblast activation protein (FAP). In future
studies, we will design a third CAR T cell trial based on the results of these two trials and on new data from
Projects 2 and 3. Project 2 will study ways to overcome heterogeneity in solid tumor CAR T cell therapy using
preclinical studies that will integrate closely with our planned clinical trials. In Aim 1, we will conduct studies to
evaluate the safety and efficacy of targeting tumor stroma using CARs targeted against anti-human fibroblast
activation protein (FAP). In Aim 2, we will explore the key issue of mesothelin and FAP CARs being able to
induce bystander effects and epitope spreading. In Aim 3, we will examine ways to augment this. Project 3
will conduct human biocorrelative studies. In Aim 1, we will study the persistence,trafficking, and function of
CAR T cells in tumors. In Aim 2, we will evaluate the hypothesis that the CAR T cells used in our clinical trials
can activate endogenous anti-tumor CD8 T cell responses (similar to the studies in Project 2). In Aim 3, we will
characterize the polyclonality of T cell responses generated by epitope spreading after CAR T cell infusion in
peripheral blood and tumors. We will benefit greatly from the unique environment of the newly established
Penn Center for Cellular Immunotherapies (CCI) led by Dr. Carl June. These projects will be supported by an
Administrative Core (with an internal and external advisory board), a Pathology/Sample Acquisition Core,
and a Biostatistics/Bioinformatics/Data Management Core. Monthly Program Project meetings will be held.
The PO1 has highly experienced leadership and the Project leaders and Core leaders have long track records
of successful collaborations and publications. Each project is highly dependent on the other projects, requiring
the Program Project format for success. The PO1 has high significance: achieving success rates with CAR T
cells in solid tumors similar to that seen in leukemia would be a major paradigm shift in the treatment of solid
tumors.
1

Public health relevance
Overall Narrative Injecting genetically enhanced T cells into cancer patients has shown remarkable success in the treatment of leukemias and other bone marrow cancers, but has not yet been nearly as successful in treating solid tumors like lung cancer and malignant mesothelioma. The goal of this Program Project is to develop approaches to reproduce the success of adoptive T cell transfer using chimeric antigen receptor (CAR) transduced T cells for hematologic malignancies to solid tumors. This will be done in 3 interrelated projects: Project 1 will conduct clinical trials with enhanced CAR T cells, Project 2 will conduct animal studies to support the clinical trials and to study ways to get the T cells to activate the patient's own immune system, and Project 3 will do biocorrelative analysis studies from the clinical trials to determine where the T cells go, how long they last, and their ability to trigger other anti-cancer immune responses. 1